RNA folding and catalysis at the interface of biophysics and genomics

Abstract
The overall vision of the Bevilacqua lab is that human health can be advanced by combining
holistic genomic and detailed molecular views of fundamental problems in RNA biology. Over the
next five years, the work outlined in this MIRA will advance RNA folding and catalysis under in
vivo and in vivo-like conditions using a combination of traditional and high-throughput (HT)
experimental and computational approaches, many of which the lab has helped develop. There
will be a balance of development of fundamental methods and new technologies with their
application. The molecular perspective employs both traditional biophysical and biochemical
approaches, while the holistic perspective uses next-generation sequencing (NGS) approaches.
A major goal of this MIRA proposal is to connect these two approaches to discover novel RNA
structures and functions and to understand them from both gene regulatory and molecular
perspectives. This proposal brings multiple high-throughput (HT) approaches to bear including
experimental approaches such as fluorescence-detected binding isotherms (FDBI), massively
parallel oligonucleotide synthesis (MPOS), and Structure-seq NGS, as well as computational
approaches ranging from cheminformatics to bioinformatics. Goals for the next five years
encompass probing RNA folding under biological conditions that include deriving an expanded
set of nearest neighbor (NN) parameters for describing RNA folding in the presence of bacterial
and human metabolite mixtures. The lab will also explore the dynamics of RNA folding in such in
vivo-like conditions using time-resolved studies such as fluorescence-detected stopped-flow
kinetics, as well as temperature-dependent probing of RNA structure in vivo to uncover cases
where only a fraction of the RNA molecules form a given pairing. Additional efforts will focus on
discovery of and novel functions for ribozymes including tolerance of mutation, metabolite
assistance of cleavage, occurrence of zymogens (‘ribozymogens’) and their activation, ribozymes
being split across exons (‘split ribozymes’), multiple turnover ribozymes, and pseudoribozymes
(loss-of-function ribozymes) and their function. Another goal will be to identify unusual charged
and tautomeric forms of the nucleobases using a combination of cheminformatics and NGS
approaches and to target these with therapeutics. The balance of traditional mechanistic
characterization and NGS approaches, as well as the widespread development and application
of HT methods, provides an ideal pathway for discovery of and insight into novel RNA biology.

Public health relevance
Project Narrative This MIRA project will help predict RNA folding in vivo and provide insight into the dynamics of RNA folding under in vivo-like conditions and in the cell. It will also help discover and elucidate novel functions for RNA enzymes and RNA motifs with rare charged and tautomeric bases. This work helps understand RNA gene regulation and identifies RNA targets for therapeutic tools.